Exploring activity-dependent regulation of intra and intercellular mitochondrial transport in astrocytes

PROJECT SUMMARY
Brain function is dependent on the precise wiring of distinct neuron types into functional neural circuits. Neurons
communicate with each other through synapses, which are carefully monitored and supported by specialized
non-neuronal cells called glia. Astrocytes are a prominent, peri-synaptic glial cell population that regulates
synapse development, synapse stability, and neuronal signaling. As neuronal signaling is an energetically
demanding process, one critical function of astrocytes is to support the metabolic needs of neighboring neurons.
In the healthy nervous system, astrocytes are known to shuttle lactate directly to neurons to facilitate neuronal
respiration and ATP generation. Recent data suggests that under pathological conditions, astrocytes can also
transfer entire mitochondria to damaged or diseased neurons to boost neuronal metabolism and restore neuronal
function. Whether astrocytes donate mitochondria to neurons under homeostatic conditions is not clear.
Furthermore, the mechanisms used by neurons to stimulate intercellular transport of astrocytic mitochondria are
poorly defined. Mitochondrial dysfunction is a hallmark of normal aging that is accelerated in neurodegenerative
disease; thus, understanding the cellular and molecular mechanisms used by astrocytes to support neuronal
metabolism is a key knowledge gap that impedes our ability to rejuvenate the brain.
To explore astrocyte-neuron metabolic coupling, we leverage Drosophila as a system where we have
precise genetic access to neurons and associated astrocytes, where we have sophisticated genetic tools for
optogenetic and thermogenetic manipulation of neuronal activity, and where we have a wealth of transgenic tools
for visualizing mitochondrial location and function. We found that stimulating motor neuron activity is sufficient to
recruit astrocyte mitochondria towards neuronal synapses and can induce astrocyte-to-neuron intercellular
transport of mitochondria. Moreover, we found that astrocyte-specific knockdown of the mitochondrial adaptor
milton completely blocked entry of astrocyte mitochondria into the synapse-rich neuropil, resulting in reduced
motor neuron activity and defective locomotor behavior. In this proposal, we continue to leverage this model
system to understand (Aim 1) what are the cellular mechanisms that position astrocyte mitochondria near
neuronal synapses and (Aim 2) facilitate astrocyte-to-neuron mitochondria transport. Finally, we aim to identify
the neuronal-activity induced cues that trigger intercellular transport of astrocyte mitochondria (Aim 3).
Ultimately, we hope that a better understanding of the cellular and molecular mechanisms that couple astrocyte
and neuronal metabolism will enhance our ability to alleviate circuit dysfunction in neurodegenerative disease.

Public health relevance
PROJECT NARRATIVE The brain requires substantial energetic input to support neuronal signaling and facilitate robust animal behavior. While neurons can produce their own energy, they largely rely on metabolic support from neighboring non- neuronal cells called astrocytes, and loss of astrocyte-to-neuron metabolic coupling results in circuit dysfunction and neuronal degeneration. The experiments outlined in this proposal explore fundamental questions related to how neurons and astrocytes communicate to support the energetic needs of the brain and ensure long-term neural circuit function.